IEEE Medical Imaging Conference

Abstract
The IEEE Medical Imaging Conference (MIC) is the leading international scientific meeting
bringing together a broad community interested in the physics, engineering, and mathematical
aspects of medical imaging, with particular emphasis on nuclear medicine and multi-modal
systems. The MIC runs in conjunction with the IEEE Nuclear Science Symposium (NSS) and the
Workshop on Room Temperature Semiconductor X-ray and Gamma-ray Detectors (RTSD).
The purpose of the MIC is to disseminate and foster new research in physics and bio-
engineering methods in medical imaging. While the traditional topics of primary interest are
related to nuclear medicine techniques such as positron emission tomography (PET) and single
photon emission computerized tomography (SPECT), increasing space will also be given to
recently evolving imaging modalities such as X-ray, CT, optical, MR, with particular emphasis on
their multi-modal combination with nuclear medical imaging. Lately, there has also been additional
interest in employing deep learning and AI to enhance the field of medical imaging. The
conference provides a well-established forum for scientific exchange and dialogue between
researchers in academia, industry, and government, as well as public education. The large
spectrum of educational refresher sessions and short courses reflects its special emphasis on
young generations. One of the primary objectives of the conference is the education of young
investigators. Therefore, this NIH R13 proposal seeks $10,000 in funding for each of the next
three years to provide 50 trainee grants of $200 each to partially cover the costs of MIC
conference registration, housing, or short course fees for graduate students and postdoctoral
fellows.
We anticipate that the main impact of this grant program will be to increase the attendance
of students and postdocs at the 2023 through 2025 meetings, especially those typically
underrepresented, and to support their participation in educational activities. It is important to
bring young generations, especially women, minorities, and those with disabilities, into the
medical imaging field, where they could become leading players in the coming years. They will
attend plenary and oral presentations given by many world leaders in the nuclear medical imaging
instrumentation, image processing, and quantitative analysis fields. Moreover, they will be given
the unique opportunity of direct personal interaction through short courses and dedicated poster
presentations. Their work will be exposed to the other participants for critical evaluation,
constructive suggestions, and dissemination. Furthermore, many of these trainees will likely
continue in this field, thereby contributing to advancing technology with high societal relevance
as it is being increasingly used in the clinical management of disease and therapeutic
interventions.

Public health relevance
Narrative The IEEE Medical Imaging Conference (MIC) aims to disseminate and foster new research in physics and bio-engineering methods in medical imaging. The conference covers a variety of medical imaging topics, including quantitative imaging, PET/SPECT techniques, image reconstruction, imaging in radiation therapy, portable imaging, multi-modality systems, new medical imaging technologies, CT/MR/optical/ultrasound, parametric/kinetic image modeling, and signal/image processing and modeling. One of the major objectives of the conference is the education and encouragement of young investigators. Therefore, this NIH R13 proposal seeks funding to provide grants for each of the next three years to graduate students and postdoctoral fellows based at US institutions to partially cover the costs of MIC conference registration or short course fees.